Medicaid Delivery System Reform Incentive Payment (DSRIP) Programs: Impacts on Health Care Use, Coordination, Outcomes, and Disparities among Patients with Mental Illness

PROJECT SUMMARY
As the largest payer for mental health care in the United States, Medicaid is adopting value-based payment
models that link provider payments to quality in an effort to improve outcomes for high-need populations,
including individuals with a serious mental illness (SMI). With over $55 billion in joint state and federal funding,
Medicaid Delivery System Reform Incentive Payment (DSRIP) programs represent the most extensive effort to
implement value-based payment in Medicaid to date. In DSRIP programs, which often emphasize mental
health care, states contract with providers to participate in performance-based incentive payment projects, with
the goal of encouraging health systems to invest in care coordination, improve surveillance of Medicaid
enrollees’ care needs and outcomes, and invest in services to address enrollees’ mental health and general
medical care needs. Thirteen states have implemented DSRIP programs to date. However, national evidence
on the impacts of DSRIP programs on patients with SMI is lacking, both overall and for sociodemographic
subgroups at high risk of experiencing poor care and outcomes. Furthermore, there is limited evidence about
which features of DSRIP programs yield positive benefits—critical to understand as key program elements vary
across states. The proposed study will address these evidence gaps by evaluating the impacts of DSRIP
programs among community-dwelling Medicaid enrollees with a diagnosis of major depression, bipolar
disorder, or schizophrenia. Using national Medicaid claims and encounter data and a difference-in-differences
design, the project has three Aims: 1) to investigate the impacts of DSRIP programs on outpatient mental
health and primary care use and health care quality measures indicative of care coordination and health
outcomes for Medicaid enrollees with SMI; 2) examine heterogeneity in the impacts of DSRIP programs among
subgroups of Medicaid enrollees with SMI along the dimensions of race/ethnicity, health complexity, disability
status, and rurality; and 3) identify specific DSRIP programmatic features that are associated with positive
impacts on Medicaid enrollees with SMI, leveraging variation across states in DSRIP program design. Because
DSRIP programs are time-limited but intended to initiate enduring delivery system improvements, analyses will
also assess longer-term impacts among Medicaid-enrolled populations with SMI. This project aligns with
NIMH’s Strategic Plan to compare alternative financing models to improve care for patients with SMI and
approaches to reduce documented disparities in care access, quality, and outcomes for disadvantaged
subpopulations (Strategies 4.1.C and 4.3.A). Findings will provide critical evidence to guide future Medicaid
payment and delivery system reforms to improve the quality and equity of health care for individuals with SMI.
To maximize this project’s impact, we will work with a Policy Advisory Council comprising experts in Medicaid
mental health policy from the government, research, and insurance sectors, building on our team’s track record
of translating health services research to inform policy.

Public health relevance
PROJECT NARRATIVE Medicaid’s Delivery System Reform Incentive Payment (DSRIP) Program—the most extensive implementation of value-based payment approaches within Medicaid—has potential to improve care for individuals with serious mental illnesses (SMI), who typically have complex health care needs requiring substantial care coordination. The study will evaluate DSRIP Programs’ impacts using quasi-experimental methods and national Medicaid claims and encounter data for non-elderly, community-dwelling Medicaid enrollees with a primary diagnosis of major depression, schizophrenia, or bipolar disorder, and it will examine variation in Program impacts across disparity subpopulations and states to understand implications for health equity and identify program features linked to improved outcomes. Evidence from this work will guide state and federal policymakers on whether and how to pursue value-based payment to improve care and outcomes for Medicaid-enrolled individuals with SMI.